The Population Research Institute: Computational and Spatial Analysis

Project Summary: PRI Computational and Spatial Analysis Core
The Computational and Spatial Analysis (CSA) core is the innovation driver for the Population Research
Institute (PRI), infusing cutting-edge methodological approaches across PRI’s primary research areas to
advance population dynamics research. The CSA core has scientific expertise and research support capacity
in data integration across multiple dimensions and scales, spatial statistics, social media analytics, innovative
and nontraditional data collection and analysis, and social network analysis. Through its specific aims, the CSA
core provides access to methodological expertise from project development through completion and
dissemination. The CSA core has four specific aims. First, the core supports the use of multi-dimensional,
multi-scale spatiotemporal data. This includes the integration and analysis of large spatial, historical, individual,
and contextual datasets. Second, the core provides services in multifaceted data support, programming,
statistical and social network expertise, and spatial statistics and analysis for innovative interdisciplinary
population research. These services also reduce investigator burden by ensuring compliance with data
providers and external agency regulations as well as access to a variety of demographic and health data.
Third, the CSA core provides resources and expertise in innovative Big Data and social media analytics for
population research. PRI is a leader in the use of social media data to advance population science. Fourth, the
core integrates cutting-edge methodologies into population research across PRI’s primary research areas with
workshops and mentoring. Although these activities are accessible to population scientists within and beyond
PRI, they are tailored to be responsive to the needs of junior scientists and to advance their competitiveness
for external funding and to raise the impact of their contributions to population research in collaboration with
the Development core. The CSA core is co-directed by senior population scientists supported by an expert
advisory board. The core is staffed efficiently to maximize research productivity and exploit existing data and
methodological infrastructure.

Public health relevance
Project Narrative – CSA Core. Not applicable